Dual p300 and p53 reactivation in HPV+ head and neck cancer

Project Summary
Incidence of HPV+ OPC has been increasing for several decades and this upward trend is expected to continue
until at least 2060. Current first-line modalities to manage HPV+ OPC patients are effective but not without
limitations. A key event in HPV-driven tumorigenesis is the inactivation of the p53 tumor suppressor program.
HPV oncogene, E6, inactivates p53 through two distinct pathways: HPVE6 promotes the assembly of the
HPVE6-E6AP-p53 trimeric protein complex resulting in ubiquitination and degradation of p53, and HPVE6
directly binds to p300 to block p300-directed acetylation and activation of p53. We hypothesized that disrupting
the HPVE6-p300 interaction will liberate sufficient p300 to restore p53 and p300 functionality simultaneously in
HPV+ OPC. Our team initiated a drug discovery platform to target the HPVE6-p300 interaction. Our work showed
that in HPV+ OPC models: (a) HPVE6 binds to the CH1 domain of p300, (b) our lead molecule, OHM1, a
CH1/p300 ligand, disrupts HPVE6-p300 interaction and reactivates p53 and p300, (c) OHM1 is active in vitro
and in vivo, and (d) concurrent OHM1+cisplatin combination treatment yields durable complete anti-tumor
responses in vivo. Our results are very compelling and, supports further research and development of dual p53
and p300 reactivation as a therapeutic strategy for HPV+ OPC. In this project, we propose to extensively
determine the mechanisms of action of p53 and p300 reactivation in response to OHM1 in HPV+ OPC. The
specific aims are: (1) determine if OHM1 modulates the p53 post-translational modification code to control p53
functionality and levels, and promote anti-cancer activity in HPV+ OPC, (2) to determine if OHM1 reshapes the
tumor-microenvironment and boost immunotherapy response in HPV+ OPC.

Public health relevance
Project Narrative Current treatments to manage HPV+ OPC patients are effective but not without limitations and, therefore, there remains an urgent need to develop more active and less toxic drugs to optimally manage these patients in the first-line and recurrent/metastatic settings. Our multi-disciplinary team developed a novel, dual p53 and p300 modulator to reactivate tumor suppressive programs in HPV+ OPC. This proposal will provide new insights on the biological consequences of restoring p53 and p300 functionality, and results generated will be leveraged to guide the drug development path of OHM1.